Role of CREBBP missense mutations in lymphomagenesis

RESEARCH SUMMARY
Non-Hodgkin lymphomas are the 5th leading cause of cancer in the United States. Among them, diffuse large
B-cell lymphoma (DLBCL) and follicular lymphoma (FL) represent the two most common forms, together
accounting for over 60% of diagnoses. Despite remarkable advances in the treatment of these diseases,
mortality remains high in as many as 40% of DLBCL patients, and FL, although regarded as an indolent disease,
is incurable in advanced stages, often transforming into a highly aggressive malignancy. Relapse and
transformation are linked to common mutated progenitor cells that maintain a subset of “founder” mutations
present in the diagnostic dominant tumor clone. Therefore, improved understanding of the biology of the common
precursor and the identification of mechanisms that could be vulnerable to targeted therapeutic intervention are
therefore a priority in order to advance our ability to cure these diseases.
Somatic mutations that inactivate the CREBBP acetyltransferase, including truncating and HAT domain
missense mutations, emerged as the second most common genetic alteration in FL (70% of cases) and DLBCL
(40% of cases belonging to the recently identified EZB/C3 genetic subset), revealing a prominent role for
epigenetic aberrations in the pathogenesis of GC-derived lymphomas (Pasqualucci et al., Nature 2011; Morin et
al., Nature 2011). CREBBP mutations represent early events during the tumor phylogenetic evolution, which are
acquired by the common mutated precursor prior to the acquisition of additional oncogenic lesions (Pasqualucci
et al, Cell Reports 2014; Okosun et al., Nature Genetics 2014). Indeed, reduced dosage of CREBBP synergizes
with BCL2 deregulation to enhance the development of human-like FL/DLBCL. While truncating mutations have
been extensively studied, the role of missense mutations remains largely unexplored. This is a significant gap
when considering that missense mutations account for the overwhelming majority of CREBBP alterations in FL,
and that different from truncating mutations, these alleles are expressed, suggesting that they could interfere
with compensatory mechanisms by other acetyltransferases or the recruitment of transcription complexes. In
line with this hypothesis, preliminary data from us and others have shown that the hotspot CREBBP missense
HAT mutation induces distinct changes compared to those observed in CREBBP-deficient cells.
Building on these results, the general goal of this project is to elucidate the impact of CREBBP missense
(vs truncating) mutations on the malignant transformation of the precursor GC B cell in vivo, with three Specific
Aims: i) investigate the in vivo role of the most common R1446H mutational hostspot in GC responses and
lymphomagenesis; ii) identify the shared vs unique transcriptional programs dysregulated by missense vs
truncating mutations in the GC B cell precursor; iii) investigate the role of CREBBP mutations in reprogramming
the GC microenvironment. We anticipate that the results obtained from these studies will provide new insights
on the mechanisms initiating neoplastic transformation and on their specific therapeutic targeting.

Public health relevance
RESEARCH NARRATIVE Follicular lymphoma and diffuse large B-cell lymphoma represent the two most common forms of human B cell lymphoma and remain incurable in a significant fraction of patients. This research proposal seeks to elucidate how missense mutations of the CREBBP acetyltransferase, the second most frequent genetic alteration in these tumors, contribute to malignant transformation by reprogramming the pre-neoplastic germinal center B cells as well as the immune microenvironment. The outcome of these studies is expected to further our understanding of the biology of these common cancers and to pave the basis for the development of improved biomarkers and therapeutic approaches.